The Center for Synovial Sarcoma Biology and Therapeutics

Project Summary/Abstract
This section is unchanged from the U54 CA231638 parent award.
The overarching goal of this FusOnC2 Center for Synovial Sarcoma Biology and Therapeutics is to develop
and execute a comprehensive, multidisciplinary set of approaches rooted in protein biochemistry and
structural biology to define the mechanistic underpinnings of synovial sarcoma and unmask opportunities for
therapeutic development. This Center’s mission is tightly aligned with that of the larger Consortium on Fusion
Oncoproteins in Childhood Cancers as well as the goals of the Beau Biden Cancer Moonshot Initiative. Indeed,
owing in part to our group’s recent findings surrounding the discovery of SS18-SSX as a stable and integrated
member of the mammalian SWI/SNF (BAF) chromatin remodeling complex, a major impetus for the
development of this Consortium has been the growing knowledge that pediatric fusion oncoproteins that
are pathognomonic for specific cancer types often function via disruption of the structure and/or activity of
protein complexes that govern chromatin architecture and hence gene control. We have shown that at least
two of the fusion oncoproteins highlighted as major areas of emphasis within the Consortium, SS18-SSX
and EWS-FLI1, act specifically through BAF complexes to drive their cancer-specific oncogenic gene
expression patterns. Study of multimeric BAF complexes and their functions, structure, and interactions are
further suggested by genetic studies across human cancer types which have indicated that among all
chromatin remodeling complexes, genes encoding mSWI/SNF complex subunits are among the most
frequently mutated, at over 20% of all human cancers.
Here we present a multi-institutional, highly collaborative and multidisciplinary approach to comprehensively
interrogate biologic mechanisms underpinning the function of the SS18-SSX oncogenic fusion in synovial
sarcoma and to use each of these approaches and the results generated to launch targeted therapeutic
discovery campaigns that are directly linked to the mechanisms identified. Specifically, our approach
encompasses three major areas: (1) BAF complex targeting, gene regulation, and chromatin state; (2)
Understanding the role of the wild-type SS18 protein in the context of the SS18-SSX fusion, its protein-level
regulation, and mechanisms by which its stabilization can be exploited for therapeutic benefit; (3) Using
genome-scale genetic perturbation strategies to discover and mechanistically characterize SS-specific
vulnerabilities, especially those in chromatin-bound protein complexes and related pathways. As a Center,
the unique expertise of each PI and the highly integrative nature of the research projects, cores, and
collaborators provide the strongest possible likelihood that the aims will be successfully achieved and that
novel therapeutic strategies will emerge from this Center.
Project Summary/Abstract Page 69

Public health relevance
Project Narrative This section is unchanged from the U54 CA231638 parent award. Synovial sarcoma is a highly aggressive soft-tissue cancer for which there exist no effective targeted therapeutic approaches despite the pathognomonic, genomically well-defined molecular lesion hallmark to every case: the SS18-SSX fusion. Understanding the function of the SS18-SSX fusion in the context of the macromolecular machine to which it binds and hijacks, as well as the features of the chromatin landscape which are uniquely permissive of these activities, represent the most critical next steps and are at present major barriers to therapeutic progress. Our Center on Synovial Sarcoma Biology and Therapeutics seeks to challenge existing paradigms, efficiently define the underlying biology, and to present the field with novel, highly-specific targeted therapeutics to combat this aggressive and devastating disease. Project Narrative Page 70